A plasma proteomic diagnostic for melioidosis

PROJECT SUMMARY
Melioidosis is a tropical infection caused by inoculation, inhalation, or ingestion of the Gram-negative soil
saprophyte and Tier 1 select agent Burkholderia pseudomallei (Bps). The overall melioidosis mortality rate
exceeds 40% in endemic areas of southeast Asia such as northeastern Thailand (despite appropriate
treatment), and modeling indicates that 165,000 cases of human melioidosis occur annually worldwide. For
decades, diagnosis of melioidosis has required culture of Bps from a clinical specimen. This may take several
days, delaying appropriate treatment, and in many resource-limited settings the necessary microbiology
facilities for bacterial culture and identification are not available. Few suitable non-culture-based diagnostics
exist. Performing a case-control analysis nested within a prospective, single-center cohort study of patients
hospitalized with infection (Ubon-Sepsis study), we have developed an eight-protein signature in plasma that,
in preliminary studies, has high accuracy differentiating melioidosis from other causes of infection. These
results suggest that measuring a limited number of circulating proteins during initial presentation has significant
diagnostic potential for melioidosis. Our central hypothesis is that this proteomic signature is a novel and
accurate diagnostic tool in identifying patients with melioidosis. To test this potentially high impact hypothesis,
we will leverage our singular expertise in melioidosis proteomics, human immunology, and access to
independent Thai and Australian cohorts of melioidosis patients in the following specific aims: 1) Externally
validate the diagnostic accuracy of the eight-protein aptamer-based signature for the detection of melioidosis in
two geographically independent prospective studies. 2) Confirm the diagnostic accuracy of the aptamer-
derived proteomic classifier for melioidosis using orthogonal immunoassays. If our hypotheses are proven, the
use of blood proteins as a melioidosis diagnostic could significantly enhance our present approaches to
identifying melioidosis. Subsequent development of this tool for clinical use could have a beneficial impact on
the burden of this often-lethal infectious disease.

Public health relevance
PROJECT NARRATIVE Melioidosis is a bacterial infection that occurs in tropical regions around the world and causes significant mortality. The objective of this project is to test a new diagnostic for melioidosis. The knowledge gained from this proposal can help to reduce the burden of melioidosis and ultimately improve public health.